Understanding how health determinants shape recovery after critical illness among Virginia Medicaid patients

PROJECT ABSTRACT. Medicaid expansion covers over 18 million low-income patients, including those
experiencing an intensive care unit (ICU) stay during serious illness. More than half of ICU survivors have new
or worsening problems with cognitive, physical, and mental health. Further, experiences of critical illness
create new health disparities and exacerbate existing ones. This study applies the NIMHD’s Research
Framework to understand how sociocultural environment, the built environment, and the health system
domains of influence at the patient, interpersonal and community-level, differentially shape ICU survivorship
among patients covered by Medicaid expansion. Such knowledge will enable state and federal policymakers
and clinicians to provide improved coordination of medical and social services for Medicaid members at the
greatest risk of poor health outcomes.
This work will leverage the resources of a well-established partnership between Virginia Medicaid and Virginia
Commonwealth University (VCU) and as well as complementary methods and data sources to better
understand how health determinants shape patients’ recovery after an ICU stay. Aim 1 assess how patient-
level and community-level sociocultural, built environment and health system domains are associated with
post-ICU hospital free days among Medicaid patients in Virginia using Virginia Medicaid claims data and
publicly available community level-data on social deprivation, segregation, rurality, ICU bed and primary care
access. Aim 2 uses qualitative research methods to expand beyond what is available in claims data by
interviewing 25 Medicaid patients to explore their perspectives on how health determinants shape their
experiences during and after ICU stays at VCU Health System, the largest safety net provider in Virginia. Aim
3 examine whether including health determinants improves machine learning models predicting hospital
readmissions after an ICU stay using electronic health record data from VCU Health System.
The proposed research is supported by Virginia Medicaid, aligning with the agency’s commitment to advancing
health equity through improving care for complex patients. Ultimately this work will provide much-needed
evidence to policymakers exploring disparities in recovery after serious illness across the sociocultural
environment, built environment and health system domains. This application describes an excellent research
and training environment for the proposed work, supported by a collaborative multi-disciplinary mentorship
team. This proposal will not only explore a novel research area, the recovery of Medicaid patients after serious
illness, but also provide integrated and robust clinical and research training in health-policy translation,
qualitative methods and community-engaged research and machine learning to a physician-scientist dedicated
to practicing critical care medicine and pursuing a faculty position with a focus on advancing health equity
through health policy.

Public health relevance
PROJECT NARRATIVE. The expansion of Medicaid increases health care access for patients experiencing critical illness, half of whom will experience new or worsening physical, mental health or cognitive function after an intensive care unit stay. The proposed work leverages complementary methods and data to understand how sociocultural environments, built environments and health systems influence Medicaid members’ recovery after an intensive care unit stay. By combining Medicaid claims, hospital & community-level public health, interviews and electronic health records datawith health services, qualitative, and machine learning research methods, this project will provide much-needed information to state Medicaid agencies formulating policies to improve the health outcomes of seriously ill patients and advance health equity.